Neural basis of behavioral timescale coordination

Behavior is organized across multiple spatial and temporal scales, ranging from
sub-second motor commands over multi-second movement plans to long term foraging patterns.
Currently it is unclear how the brain solves this coordination of multiple intertwined
temporal demands. While classical neuroscience experiments typically look at or engage a
fixed temporal scale or horizon, ethological studies have long focused on the analysis of
naturalistic behavior across freely elicited temporal scales. Here we will use novel developed deep
learning pose estimation approaches to study the behavior and associated single unit physiology of
foraging behavior in freely moving rhesus macaques. First we will establish that timescales of
macaque pose behavior encode cognitive variables such as reward expectation. Second we will
establish the link between neural and behavioral timescale coordinating in the decision to
action axis of the medial prefrontal wall leading to the anterior cingulate cortex by
recording multi-region wireless electrophysiology in freely moving rhesus macaques. Third,
using embedding and connectivity analysis we will uncover the mechanisms for inter and intra areal
timescale coordination to understand how the brain balances temporal scale demands.

Public health relevance
Long term plans as well as moment to moment dynamic adjustments are a hallmark of flexible behavior and the disruption of this ability is a common symptom in many psychiatric illnesses. The brain's ability to coordinate between different temporal demands is a neuronal process that is currently not well understood and the proposed studies, using a novel unconstrained and quasi-naturalistic approach, will fundamentally advance that understanding.